Dyadic Sleep, Biobehavioral Rhythms and Cognitive Function in Older Adults: Implications for Alzheimer’s Disease

Abstract
Individuals with mild cognitive impairment (MCI) demonstrate cognitive decline without major functional
impairment but also experience a 7-fold increased risk for developing Alzheimer’s disease, a leading cause of
poorer quality of life (QOL), premature mortality, and health care expenditures. Sleep and biobehavioral rhythm
disturbances (disruptions in 24h oscillations in physiology and behavior, including rest-activity patterns and
mealtimes) are more than twice as common among patients with MCI than cognitively intact older adults.
Emerging evidence demonstrates a mechanistic role of sleep and biobehavioral rhythm disturbances in
cognitive decline and the development and progression of Alzheimer’s disease. Importantly, the consequences
of sleep and biobehavioral rhythm disruption in MCI extend beyond the patient, also affecting the
spouse/partner, as sleep is a “shared” health behavior for most adults. However, sleep and biobehavioral
rhythms are typically considered at the level of the individual. Building on our team’s pioneering work on sleep
as a shared experience among couples, we propose to investigate sleep and biobehavioral rhythms as
fundamental dyadic processes that contribute to the health and cognitive functioning of individuals with MCI or
mild AD and their partners. We will evaluate the daily and longitudinal effects of two dyadic processes in sleep:
interdependence (partners’ sleep patterns influence on each other) and concordance (i.e., the couples’
similarity in rest/activity and social rhythms such as meal timing). We will conduct a 14-day naturalistic study
protocol in order to examine the mechanistic associations between sleep and biobehavioral rhythms and
proximal indicators of daytime functioning, within a sample of 170 couples in which one partner evidences
cognitive impairment (MCI to mild Alzheimer’s disease). During the naturalistic study protocol, we will capture
sleep and biobehavioral rhythms via objective (actigraphy) measures of sleep and circadian rest-activity
rhythms and daily social rhythms, respectively. Also, we will include daily assessments of mood and
relationship quality, and we will use an innovative smartphone cognitive assessment that has been validated to
measure cognitive function in daily life. In addition, we will conduct comprehensive neuropsychological
assessments at baseline and again at two-year follow-up to examine how sleep and biobehavioral rhythm
disruptions at baseline predict cognitive decline over 2 years in both partners. Results of study will advance the
understanding of the daily and longitudinal relationships between the individual and couple-level processes in
sleep and biobehavioral rhythms that influence the progression of cognitive decline in a population at increased
risk for developing Alzheimer’s disease.

Public health relevance
Project Narrative Alzheimer’s disease and related dementias (ADRD), including mild cognitive impairment (MCI), are becoming among the most prevalent causes of disability, death and healthcare costs worldwide. Sleep and circadian rhythm disturbances are common among individuals with MCI as well as their spouses/ partners and may increase risk of the development of ADRD in both patients and partners. This is the first study to systematically investigate sleep as a shared health behavior within couples in which one member has MCI, and the degree to which sleep and circadian disturbances impact both partners health and well-being, including cognitive decline and risk for ADRD.